North Texas Transition Program in Biomedical Science

[unreadable] DESCRIPTION (provided by applicant): Texas Woman's University (TWU) and Tarrant County College (TCC) propose to continue their transition program in biomedical science. In addition, North Central Texas College (NCTC) and Collin County Community College (CCCC) propose to join the program. The program goal is to assist more individuals from underrepresented minority groups to pursue a baccalaureate degree in mathematics or science so they can eventually obtain a Ph.D. degree and build a career in biomedical research. The program objectives are: 1) to serve ten students from each of the three community college as participants in each of three funding years (approximately 30 students per year); 2) to help participants excel in the classroom through individualized tutoring, advising and a student support group; 3) to provide opportunities for participants to learn more about biomedical research by offering seminars, laboratory tours, a summer preparatory course for research, research-related events and access to research faculty as well as peer mentors; 4) to provide opportunities for all participants to obtain experience in research; 5)) to motivate and guide at least [unreadable] 90% of the participants to transfer to a four-year college/university; 7) to motivate and guide at least 90% of those who transfer to a four-year college/university to complete their baccalaureate degree; and 8) to motivate and guide at least 90% of former participants who earn their baccalaureate degree to enter graduate programs in biomedical science with plans to pursue a career in biomedical research. Program evaluation and student tracking will be both continuous and comprehensive to ensure that the program is as effective as possible. [unreadable] [unreadable]